PURCHASE OF A 500 MHZ NMR SPECTROMETER

Acquistion of a 500MHz NMR instrument to support NIH funded research at Florida State University is proposed. The instrument will be available for the use of other research users as time permits. The primary user group plans to use high field (correlation) spectroscopy to support NIH funded projects involving the conformation and binding of polypeptides, DNA conformational dynamics and counterion dynamics in liquid crystalline phases, studies of metalloenzymes and connective tissue metabolism, and synthetic studies directed toward the anti-tumor agents taxol and aphidicolin. This group also plans new studies, related to the above projects which will become possible for the first time when the proposed instrument is acquired. These studies include solvent dependent conformational studies of polypeptides, conformational studies of DNA minihelices and their complexes with carcinogens, and studies involving new synthetic approaches to complex polyether antibiotics, especially the brevetoxins.